Signal transduction and gene induction in lymphocytes

ABSTRACT
Modern immunotherapies have had a broad impact in clinical oncology. CAR T cell therapy has been dramatically
successful against certain hematologic malignancies, and ‘immune checkpoint blockade’ targeting the PD-1/PD-
L1 pathway or other T cell inhibitory pathways has proven to be an effective treatment for advanced solid tumors
in a subset of patients. On the other hand, CAR T cell therapy has had only limited success against solid tumors,
and many patients treated with immune checkpoint blockade either do not respond or experience tumor
recurrence. One shared factor limiting the ability of these treatments to control cancer is that tumor-infiltrating T
cells become ‘exhausted’. We need to understand immune cell exhaustion at a molecular level, both in mouse
models and in humans, in order to design therapies that will be more effective at eradicating the original tumor
and in fostering the development of tumor-specific memory cells that will prevent a recurrence.
We discovered some years ago that the transcription factor NFAT— classically a main driver of T cell effector
responses— also initiates T cell exhaustion. T cell receptor stimulation paired with effective costimulation
activates NFAT and its transcriptional partner AP1, and drives the effector response. However, NFAT
simultaneously activates a separate cell-intrinsic program that damps down T cell responses, with the relative
strength of the two transcriptional programs depending on the context. In tumors, the hyporesponsiveness
program is favored, leading to T cell exhaustion. We recently identified TOX- and NR4A-family transcription
factors as genes induced by NFAT that cooperate with NFAT to further the exhaustion program. It has been
thought that exhaustion is a gradual process, but in fact we have demonstrated that TOX mRNA and TOX
protein— along with other markers of exhaustion— are sharply induced in tumor antigen-specific CD8+ T cells
almost immediately when they encounter a tumor. This means that CAR T cells or expanded tumor antigen-
specific T cells are immediately at risk when they are infused into a patient, perhaps explaining the requirement
for transferring large numbers of cells, and accounting in part for the limited success of the therapies.
Here, we plan to address the fundamental transcriptional mechanisms controlling the onset of exhaustion, as a
background for eventually circumventing this problem in the clinic. In Aim 1, we will define the ensemble of
transcription factors and, by extension, the cellular signalling pathways that drive TOX expression and lead to
exhaustion. In Aim 2, we will probe how TOX then furthers the exhaustion program by directly controlling key
exhaustion-specific genes. In Aim 3, we will address the very practical question whether TOX protein levels in
tumor-infiltrating lymphocytes can be titrated to prevent or reverse exhaustion, taking an approach that could in
principle be developed further for clinical use.
Our results will contribute to a broad mechanistic understanding of key transcriptional mechanisms operating in
mouse and human tumor-infiltrating T cells.

Public health relevance
NARRATIVE CD8+ cytolytic T cells constitute an important limb of the immune response against tumors. Often, though, CD8+ T cells and their engineered derivatives such as CAR T cells become ‘exhausted’ in the tumor environment, devolving into a state with reduced ability to kill tumor cells. In this project, we will continue our longstanding collaboration to investigate intracellular mechanisms that determine whether a CD8+ T cell will or will not mount an effective immune response.